Research Training in Natural Product Complementary and Integrative Health

Project Summary/Abstract
Of the >100 pharmacy colleges in the U.S., the University of Illinois at Chicago (UIC) College of
Pharmacy is the third oldest, founded in 1859, and is even older than the University of Illinois
itself. The UIC College of Pharmacy consistently ranks in the top five nationally for overall
research expenditures by AACP and for NIH funding. Enrolling an average of 120 graduate
students at any one time, this renewal application seeks support for our most prestigious
program in natural products research and graduate education: the Program for Collaborative
Research in the Pharmaceutical Sciences (PCRPS), which was founded by the late Prof.
Norman Farnsworth. PCRPS has a global reputation of excellence in graduate education and
postgraduate training, with hundreds of alumni worldwide. The signature of this program is its
emphasis on interdisciplinary and collaborative approaches to graduate education in natural
products of biomedical relevance. The PCRPS incorporates our Pharmacognosy graduate
program, one of just two such programs in the U.S., a postdoctoral and scholarly training and
exchange program in Pharmacognosy including the UIC WHO Traditional Medicines
Collaborating Center, and Medicinal Chemistry graduate and postgraduate training with a
natural products focus. Since 1999, the UIC College of Pharmacy is also home to the UIC/NIH
Center for Botanical Dietary Supplements Research, which is the oldest NIH-supported
Botanical Center. Directed by the PI, Dr. Pauli, the UIC Botanical Center evaluates the safety
and efficacy of botanical dietary supplements that are used widely by menopausal women in the
U.S. With approximately 50 PhD graduates so far, this Center has been a major focus of
graduate education in natural products research. The recently established Center for Natural
Product Technologies (CeNAPT) has further expanded this educational opportunities for our
trainees. Mentored by a large group of well-funded faculty with expertise in natural products
research, our graduates move on to leadership positions in academia, industry, regulatory, and
government here in the U.S. and all over the world. Training young scientists for careers in
natural products research is a core mission of our College of Pharmacy, the PCRPS, and the
Botanical and CeNAPT Centers, and the focus of this training grant.

Public health relevance
Project Narrative The majority of drugs and dietary supplements (DSs) in use today are derived from or represent natural products. This training grant will support the education of the next generation of scientists that have the knowledge and skills to discover new therapeutic agents from natural product sources and be responsible for establishing the safety and efficacy of DSs.